Innovative technologies to transform antibiotic discovery. Project 3 Rapid Access to Antibiotic Biosynthesis Machinery Using Synthetic Biology

Project Summary/Abstract
The WHO and CDC have declared Gram negative antibiotics as one of the greatest unmet needs. Indeed, the
accelerating problem of antibiotic resistance threatens up to 10 million lives/year. Despite the urgent need for
new antibiotics, Gram negative organisms are challenging to target because they have impermeable
membranes and efflux pumps to resist xenobiotics. Complicating matters, identifying novel natural products
remains, a significant challenge: i) classic approaches that use bioactivity-guided fractionation of organism
extracts are slow; ii) removed from the context of their native or symbiotic environments, microbial organisms
cannot always be coaxed into producing their varied metabolites in the lab; and iii) heterologous expression in
different hosts remains a limitation. In work leading up to this proposal, we have developed versatile synthetic
biology platform that can overcome each of these challenges. Here, we will use this platform to produce
large libraries of potential antimicrobial molecules including >10,000 natural product derivatives,
>100,000 lectin variants, and >1M cyclic peptides. The output from our platform will be screened
against Gram negative pathogens. A key innovation of our platform is that enzymes in a biosynthetic
pathway are overexpressed lysates or made in cell-free protein synthesis to construct cell-free “units” following
a chemical engineering paradigm that can then be used to recreate the pathway or combinatorially diversify it.
We have recently made key advancements in DNA sequencing workflows, microfluidics, cell-free systems,
machine learning, and screening platforms to facilitate our goals. In Aim 1, we will develop a unit operation
based antibiotic expression systems and generate libraries of novel compounds. In Aim 2, we will generate
libraries of antimicrobial peptides in stable cyclic scaffolds. In Aim 3, we will extend our technology to generate
libraries of lectins that target Gram negative pathogens. In Aim 4, which connects to all other aims, we will
screen libraries from Aims 1, 2, and 3 for biological activity. We expect that our discovery-centered approach
will be the first of its kind in offering high-throughput experimentation in a cell-free environment. It will uniquely
(i) avoid inherent limitations of whole-cell viability, (ii) permit design-build-test (DBT) iterations without the need
to reengineer organisms, and (iii) explore combinatorial and modular assembly of pathways through the use of
well-defined experimental conditions that can use chemical and physical manipulations not possible in cells.
This work will add new knowledge for the biosynthetic mechanisms responsible for the privileged class of
natural product antibiotics and provide us with tools to systematically engineer them. Furthermore, it will deliver
new chemical matter to serve as starting points for optimization and development of therapeutics.

Public health relevance
Project Narrative The accelerating problem of antibiotic resistance threatens up to 10 million lives/year, and is especially concerning for Gram negative organisms that are challenging to target because they have impermeable membranes and efflux pumps to resist xenobiotics. To address this challenge, we use a newly developed cell- free framework for discovery and production of biosynthetic pathways involved in antimicrobial natural product synthesis. Our discovery-centered approach will be the first of its kind in offering high-throughput experimentation driven by next generation sequencing, synthetic biology DNA design, and cell-free systems, opening the way to elucidating fundamental understanding relevant to health, and delivering new potential antimicrobial molecules such as natural product derivatives, lectin variants, and cyclic peptides against Gram negative pathogens.